Graph Learning of Cell-cell Communications in Spatial Transcriptomics

PROJECT SUMMARY
Research Project: Many mechanisms of intercellular communications in tissue depend on the physical proximity
between cells. Spatial barcoding-based transcriptomic data provide important and essential information to
understand intercellular communications in intact tissue by measuring transcriptomic data and spatial locations
of cells simultaneously. However, analysis of these data to understand intercellular communications faces the
following challenges. First, spatial barcoding-based transcriptomic data lacks single-cell resolution, and cell type
deconvolution is needed to infer cell-cell communication networks (CCCNs). Second, it is critical but challenging
to integrate spatial information with prior knowledge of ligand-receptor interactions and downstream regulated
genes for CCCN inference. Finally, difference in the distribution of CCCNs between disease and control groups
needs to be assessed to identify disease associated CCCN perturbations. Current methods are not able to
account for spatial correlation of cell type compositions between neighboring cells in cell type deconvolution nor
to integrate prior knowledge of ligand-receptor pairs and downstream regulated genes in CCCN inference. There
is no existing method developed to compare CCCNs between two groups of subjects. The goal of this application
is to develop accurate, robust, and efficient bioinformatic and computational tools to deconvolve spatial
barcoding-based transcriptomic data, infer CCCNs using spatial transcriptomic data, and assess differences in
CCCNs between two groups of subjects. Our long-term objective is to identify disease associated intercellular
communication changes from spatial transcriptomic data beyond what has been discovered by investigating
individual cell types or cells. To achieve this goal, we propose to 1) develop a graph Laplacian regularized model
to deconvolve spatial barcoding-based transcriptomic data using scRNA-seq data from same tissue type with
integration of spatial information; 2) develop a regularized graph attention network model to infer CCCNs by
integrating spatial information, prior knowledge of ligand-receptor pairs and corresponding downstream
regulated genes; and 3) develop a graphical generative model that compares CCCNs between disease and
control samples to identify disease associated perturbations in intercellular communications.
Research design and methods: Drs. Xiting Yan and Zuoheng Wang will jointly lead the proposed research
together with collaborator Dr. Naftali Kaminski, a team of experienced, committed experts in the fields of
bioinformatics, statistics, genomics and genetics, biology, translational research and precision medicine.
Regularized graph learning models will be developed. The datasets for our main study populations will come
primarily from Dr. Kaminski’s lab, which will also execute discovery validations and downstream functional
studies. R and python packages will be developed and freely distributed as open-source software in a light
weight, portable and self-sufficient way using containers.

Public health relevance
PROJECT NARRATIVE To fully unleash the power of spatial barcoding-based transcriptomic data in studying intercellular communications in intact tissue, our research effort will be devoted to developing accurate, robust, and efficient graph learning based approaches for data deconvolution, cell-cell communication network (CCCN) inference, and detecting disease associated CCCN perturbations using spatial transcriptomic data. The ultimate goal is to enhance bioinformatic and computational tools for analysis of spatial transcriptomic data and to advance the understanding of intercellular communication changes in disease for precise therapeutic development.